Developmental Research Program

PROJECT SUMMARY (Developmental Research Program)
The specific objectives of the Developmental Research Program are to:
1. Publicize the availability of funds for pilot translational research studies in the field of Epigenetic Therapy
for cancers.
2. Identify through this mechanism innovative projects with significant potential for developing and improving
Epigenetic Therapies for cancers.
3. Encourage collaborations of projects with scientists within the SPORE and outside the SPORE,
specifically the Van Andel Institute-Stand Up To Cancer Epigenetics Dream Team (VAI-SU2C).
4. Enhance the communication between the SPORE leaders and VAI-SU2C Investigators to encourage the
development of innovative epigenetics therapies for cancer.
5. Ensure program flexibility so that developmental projects that show promise can be: 1) funded for a
second year; 2) encouraged to apply for peer-reviewed funding (i.e. R01); or 3) expanded to become full
SPORE projects.
The structure and processes of this program are modeled after a long-standing and successful Developmental
Research Program within the MDACC Leukemia SPORE, and on the success of the VAI-SU2C Epigenetics
Dream Team in soliciting, reviewing, awarding and monitoring developmental research project proposals. To
achieve our aims, we will establish 1) specific criteria for selection and funding through a peer review mechanism,
and 2) mechanisms for close monitoring of, and collaboration between the SPORE leaders and program
awardees to enhance the quality of the translational research goals.

Public health relevance
PROJECT NARRATIVE (Developmental Research Program) The Developmental Research Program aims to support and develop research projects involving cancer epigenetics therapies with translational potential that will ultimately improve the survival and the quality of life of cancer patients.